Language Processing in Children & Their Parents

PROJECT SUMMARY
The proposed study complements that of its parent study on dialect detection in school-age
children, 1R21DC019997-01A1. In this project, we use webcam-based eye-tracking technology
to compare processing of Mainstream American English (MAE) with Non-Mainstream American
English (NMAE). The aim of the study is to move beyond the status quo in the eye-tracking
literature which compares children to a group of college-student adults. We will compare dialect
detection of children with their parents to capture real time language processing, using an online
platform.
Our central hypothesis is that children with stronger language skills will be sensitive to violations
of phonology and grammar in NMAE and MAE, but that children with weaker language skills will
show little sensitivity to such violations. Our hypothesis has been formulated based on extant
research linking children’s processing speed with language ability (Borovsky, Elman, & Fernald,
2012; Law et al., 2017). Likewise, we expect parents to display faster processing skills than
children given this adult advantage in the literature examining online processing of phonology
(Zamuner, Moore, & Desmeules-Trudel; 2016), morphology (Gómez, Holtheuer, Miller, &
Schmitt, 2021), syntax (Huang & Snedeker, 2013; Trueswell, Sekerina, Hill, & Logrip, 1999),
and unaccented nouns and pronouns (Arnold, 2008). Yet, most of the literature compares
children to college students, rather than to their parents. Therefore, to extend the extant
literature, we compare children’s online processing with that of their parents, which we
anticipate will be correlated. We plan to attain the overall objective by pursing the following
specific aims: (1) to apply eye-tracking to evaluate sensitivities to violations of phonology in both
MAE and NMAE, in 7-year-old children and their parents; and (2) to prepare for enrollment in an
advanced degree program in communication sciences and disorders.
At the completion of the proposed project, our expected outcomes are to have identified key
dialect detection profiles of typically-developing children and their parents. These results will
provide a foundational evidence base on dialect detection across the lifespan, supplying insights
into normative development that have potential applications to the treatment of developmental
language disorder.

Public health relevance
PROJECT NARRATIVE This exploratory study is relevant to public health in that it provides proof-of-concept evidence for the existence of dialect mismatch effects across the lifespan. Secondly, this project aligns with the NIH’s mission to develop social and behavioral scientists from underrepresented minority backgrounds. .